The role of UTX in Epidermal Homeostasis, Carcinogenesis, and Sex Mediated Risk of Cutaneous Squamous Cell Carcinoma

ABSTRACT
Histone modifiers are amongst the most highly mutated genes in all forms of cancer, with the histone
demethylase UTX (KDM6A) being one of the most frequent. UTX is mutated in several epithelial cancers
including cutaneous squamous cell carcinoma (cSCC), the second most common type of all human
malignancies. UTX is found on the X chromosome and is a major enhancer regulator. It establishes the active
enhancer landscape through its histone demethylase activity as well as its ability to complex with other
activating histone modifiers. UTX is also known to escape X inactivation creating a dosage disparity between
males and females that may account for some of the sex specific differences observed for both the risk and
severity of certain types of cancer, including cSCC. In support of this, when constitutively knocked out in all
tissues, UTX loss results in embryonic lethality in all females, while ~25% of males survive to adulthood.
Interestingly, UTY, the Y-linked paralog of UTX, retains minimal demethylase function but potentially
compensates for loss of UTX through other mechanisms. In addition to its involvement in sex specific
differences, UTX is implicated as a tumor suppressor in several epithelial cancers. Recently, UTX has also
been shown to sense cellular oxygen. Accumulating data suggests that UTX is critical for proper cellular
homeostasis and plays fundamental roles in development and carcinogenesis. However, despite this evidence
and the high incidence of UTX mutations in cSCC, there is virtually no understanding of how this enzyme
functions during epidermal homeostasis and carcinogenesis. To investigate this, we have generated mice with
epidermal specific deletions of Utx where only female Utx knockout mice display any obvious abnormalities.
Specifically, homozygous knockout female mice present with reduced size as well as erythematous, scaly skin
compared to littermate controls. H&E staining of the skin harvested from these mice reveals premalignant
changes such as epidermal hyperplasia. When knocked down in primary human keratinocytes UTX loss leads
to dramatic transcriptional changes. Hypoxic response genes and those involved oxidative phosphorylation are
among the most differentially expressed. These data provoke the hypothesis that UTX is critical for the proper
homeostatic gene expression, and when lost lead to altered metabolism and higher cancer risk. To test this
hypothesis, I will carry out the following aims: In Aim1 I will determine how Utx loss affects epidermal
homeostasis in vivo and investigate its role in hypoxia and metabolism in the epidermis. In Aim2 I will use UV-
radiation to induce tumorigenesis in our Utx knockout mouse model to determine if Utx acts as a tumor
suppressor in the epidermis. I will also assess how tumor risk and severity is affected by Utx loss between
males and females to glean insights about sex specific differences driven by UTX copy gene dosage.
Furthermore, given the inherent reversibility of epigenetic changes, these studies hold promise to provide new
insight into the potential for epigenetic therapies for these incredibly common cancers.

Public health relevance
PROJECT NARRIATIVE Cutaneous squamous cell carcinoma (cSCC) is the second most common of all human malignancies with one million cases treated annually in the United States and fatality rates rivaling those attributed to melanoma. Collectively, the results from this proposal will define the role of the epigenetic modifier UTX in the skin and how its dysfunction may promote cSCC. Furthermore, the inherent reversibility of epigenetic changes holds promise to provide insight into possible therapeutic strategies to reduce cost of treatment and fatality rates for these incredibly common cancers.